Computational Enzymology to Study Diverse Catalytic Strategies of RNA

Computational Enzymology to Study Diverse Catalytic Strategies of RNA
PI: Darrin M. York, Rutgers University, Piscataway, NJ 08854-8087 USA.
RNA enzymes (ribozymes) are fundamental in biology, and have important applications in chemistry, biotech-
nology and medicine. The scientiﬁc community is still in early stages of discovery, and the full breadth of poten-
tially transformative RNA and related nucleic acid based technology and therapeutics have yet to be realized. A
critical barrier to progress toward this realization is the lack of a predictive understanding of ribozyme mechanisms
that can be used to guide design. This proposal addresses this critical barrier by the creation of new enabling
technology to study RNA enzymes (Aim 1) that will be applied to small self-cleaving (nucleolytic) ribozymes (Aim
2), and artiﬁcially engineered self-alkylating and methyltransferase ribozymes and a naturally occurring group I
intron ribozyme (Aim 3). Predictive insight gained from these studies will unveil general principles crucial for our
understanding of RNA catalysis and the rational design of new ribozyme-based biomedical technology.
Aim 1 will create advanced tools for computational RNA enzymology, including 1) new fast/accurate quan-
tum+machine learning force ﬁelds for RNA catalysis, 2) integrated software for inclusion of nuclear quantum
effects, and 3) robust methods for determination of reaction paths and free energy surfaces (including corrections
to expensive high-level ab initio surfaces). These methods are signiﬁcant as enabling technology to study mech-
anisms of RNA catalysis. The goal of this aim is develop innovative technology designed to meet the needs of the
driving ribozyme applications in Aims 2 and 3, as well as many applications outside the scope of the proposal.
Aim 2 will apply our computational enzymology tools to study the catalytic mechanisms of small nucleolytic
ribozymes (Psr, HHr and HDVr) and a related artiﬁcially engineered DNAzyme (8-17dz). These systems are
important as tools for chemical and molecular biology, and as tractable models for RNA/DNA catalysis. The
goal of this aim is to apply and further develop general principles for RNA-cleaving nucleic acid enzyme design,
building on our L-platform/L-scaffold framework for naturally occurring “G+A” and “G+M” ribozyme classes.
Aim 3 will explore mechanisms of artiﬁcially engineered self-alkylating ribozyme (SAR) and methyl transferase
ribozyme (MTR1), and the naturally occurring Tetrahymena group I intron (THr) ribozyme. These systems have
far-reaching implications for biotechnology and medicine. The goal of this aim is to examine the extent to which
design principles can be extended and transferred to these systems to provide deeper insight into the diverse
array of catalytic strategies available to nucleic acid enzymes.
Working together, these aims will accomplish the overarching goal to achieve a predictive understanding of
ribozyme mechanisms that can be used to guide the design of new technology and therapeutics.

Public health relevance
Computational Enzymology to Study Diverse Catalytic Strategies of RNA PI: Darrin M. York, Rutgers University, Piscataway, NJ 08854-8087 USA. RNA enzymes are fundamental in biology, and have important applications for chemistry, biotech- nology and medicine. The goal of this proposal is to develop and apply a novel computational RNA enzymology approach to gain a predictive understanding of the diverse array of catalytic strate- gies exhibited by RNA enzymes. Powerful computational tools and insightful guiding principles for ribozyme engineering are likely to emerge that enable the design of new biomedical technology and therapeutics.